Active Arm-Support Industrial Exoskeleton to Reduce Work-Related Musculoskeletal Disorders (WRMSDs)

Project Summary/Abstract
The proposed project focuses on creating an active assistance arm-support exoskeleton to reduce work-
related musculoskeletal disorders (WRMSDs) in careers requiring manual labor. Significance: WRMSDs are
highly prevalent and costly in industrialized countries, causing the sufferers significant personal, social, and
economic pain. The majority of these ailments occur in the upper body (arms, back and neck regions). The
main objective of industrial exoskeletons is to aid workers by reducing the physical fatigue, discomfort, and
overuse injuries caused by performing repetitive overhead and lifting motions. The current generation of
passive industrial, upper-body exoskeleton store energy mechanically by loading a spring during the arm
descending phase. This action impedes the user's normal motion and shifts energy expenditure rather than
supplement it. Hypothesis: We hypothesize that the creation of an intelligent, active exoskeleton can eliminate
this shortcoming and improve user satisfaction by providing more lifting assistance dynamically on demand.
Specific Aims: In Phase I the following aims are proposed: 1) Perform pilot data collection, 2) Develop Active
Industrial exoskeleton prototype with user intent control, and 3) Evaluate system performance and validate
safety.

Public health relevance
Project Narrative Musculoskeletal disorders are a group of painful disorders of soft tissues (i.e., muscles, tendons, nerves, joints, cartilage, and ligaments). Despite the ongoing mechanization of manual labor, work-related musculoskeletal disorders are highly prevalent and costly in industrialized countries, causing sufferers significant personal, social, and economic pain. In the US, over 4.5 million work-related injuries occur per year, accounting for 104 million lost production days.